Stimulant Overdose in the Medicaid Population: Who is at Risk, and When are They at Risk

The US drug overdose epidemic in the has grown dramatically in the past twenty years, with more than 70,000 fatal drug
overdoses in 2019 alone. This growth in overdose deaths is a major contributor to the multiyear decline in US life
expectancy that was seen even before the COVID-19 pandemic began. The drugs responsible for the largest increases in
overdose deaths are synthetic opioids, cocaine, and other stimulants (primarily methamphetamine). In recognition of
the increasing role that cocaine and other stimulants are playing in the drug overdose epidemic, the US Centers for
Disease Control and Prevention (CDC) has called for increased surveillance and evidence-based prevention and response
strategies to address overdoses involving these agents. While rates of stimulant use and overdose have been reported
vary by demographics, physical and mental health conditions, disability, and other factors, no prior research has linked
individual-level data on demographics, disability, and social determinants of health together with granular measures
derived from healthcare utilization records, with comprehensive, area-level data on social deprivation to develop
knowledge about risk and protective factors for stimulant overdose. Further, no prior research has focused on stimulant
overdose in Medicaid enrollees, a large, vulnerable, underserved population in whom half of all amphetamine-related
hospitalizations occur. This project addresses Objective 2 of RFA-CE-21-002: to assess risk and protective factors for illicit
stimulant use, use disorder, or overdose that can contribute to the development or adaptation of intervention
strategies. The study will 1) develop and validate a model using both person-level characteristics (including demographic
characteristics, household income, diagnoses, prescriptions, and healthcare utilization) and area-level characteristics
(including a wide range of measures of socioeconomic deprivation) to identify, among Medicaid enrollees age 15 and
older, who is at highest risk of an emergency department (ED) encounter for overdose from cocaine or other stimulants;
2) develop and validate a model to identify, among those Medicaid enrollees age 15 and older at highest risk of an ED
encounter for stimulant overdose, when they are at highest risk; and 3) among those Medicaid enrollees age 15 and
above with a prior ED encounter for stimulant overdose, to measure the rate of and identify risk and protective factors
for a subsequent ED encounter for overdose from stimulants and/or opioids. The results will be useful in at least two
ways. First, they will provide generalizable knowledge about the individual-level and social factors that predispose to or
protect against stimulant overdose. Such etiologic factors can then be the targets of intervention at the national, state,
county, and local levels to ameliorate the effects of these causes, as well serve as the basis of future research to better
understand the underlying causal mechanisms. Second, the results can be used pragmatically to identify high-risk
individuals for the purpose of targeting scarce resources for evidence-based approaches to overdose prevention.

Public health relevance
This project will identify which Medicaid enrollees are at highest risk for stimulant overdose, and when they are at highest risk. The study’s results will provide generalizable knowledge about individual-level and social factors that predispose to or protect against stimulant overdose. Such factors can be the targets of intervention at the national, state, county, and local levels to ameliorate the effects of these causes, as well serve as the basis of future research to better understand the underlying causal mechanisms. The results can also be used pragmatically to identify high-risk individuals for the purpose of targeting scarce resources for evidence-based approaches to overdose prevention.